Estrogen regulation of age and PTSD-associated changes in macrophage-induced neuroinflammation during HIV infection.

Project Summary/Abstract
30-50% of persons living with HIV still suffer from neurological co-morbidities, including HIV-associated
Neurocognitive Disorders (HAND) and Post-traumatic stress disorder (PTSD), despite the success of combined
Antiretroviral Therapy (cART). Persistent macrophage and microglia driven neuroinflammation is seen as a
common underlying factor in HAND and PTSD disease progression. The long-term objective of this research is
to understand the underling mechanisms that influence neuroinflammatory processes in neurological disorders
to target more specific endogenous signaling mechanisms for development of novel therapeutic approaches. In
this study we will explore estrogen signaling in macrophages and microglia as a possible therapeutic target. 17β-
estradiol, the most active form of estrogen, is reduced in postmenopausal women. Studies have shown that 17β-
estradiol is neuroprotective and its reduced expression may correlate with worse HIV and PTSD disease
progression. However, how changes in estrogen concentrations and its receptors may modulate HIV-induced
neurocognitive impairment in the post-menopausal women living with PTSD is unknown. Therefore, we
hypothesize that macrophage and microglia induced neuroinflammation will be suppressed by estrogen,
in an GPER dependent manner, in the aging female compared to males and pre-menopausal females
living with Post-traumatic stress disorder and HIV. To address this hypothesis, we will utilize 2 in vitro HIV
neuroinflammatory models: 1. A co-culture system composed of rat cortical neurons and human monocytes
derived macrophages isolated from PTSD donors and 2. A co-culture system of iMicroglia and iNeurons derived
from human pluripotent stem cells from healthy donors. iMicroglia and macrophages from pre and
postmenopausal women and aged matched men will be pretreated with various concentrations of estrogen prior
to HIVADA exposure to explore the following Specific Aims: 1) Evaluate estrogen’s ability to suppress HIV-
induced neuroinflammation in PTSD-hMDM and Microglia. 2) Evaluate the role of estrogen receptors in
HIV and PTSD-induced neuroinflammation. In this proposed award, we expect hMDMs from post-menopausal
female PTSD donors and iMicroglia will have increased HIV-induced neuroinflammation, which can be
suppressed by GPER activation. The principal investigator’s career goals are to lead an independent translation
research program while increasing diversity in the sciences at a Historically Black College and University
(HBCU). To accomplish this, the PI has developed a strong training plan that will expand her expertise in the
NeuroAIDS and PTSD field, increase her skillset in the generation of iPSC, flow cytometry, mass cytometry,
biostatistical analysis and generate data for future R awards. This training will be guided by the strong mentoring
committee of investigators from Spelman College and neighboring Research 1 institutions. With success of this
project, we will elucidate the role of estrogen signaling as a potential endogenous targeted therapeutic avenue
for persons living with HAND, PTSD and other neuroinflammatory disorders.

Public health relevance
Project Narrative Despite effective HIV viral control and longer life expectancies due to the success of combined Antiretroviral Therapy (ART), persons living with HIV continue to suffer from neurological complications including Post- traumatic stress disorder (PTSD) and HIV-associated Neurocognitive Disorders (HAND). These complications are predicted to accelerate as patients age and understanding of how a loss of estrogen in the aging population of women living with HIV and PTSD is needed. We will characterize estrogen signaling as a potential endogenous targeted therapeutic avenue to the current antiretroviral arsenal to reduced neuroinflammation, in the aging population of females living with HAND and PTSD.